The creation of a digital shareable archive of high-resolution images of the human temporal bone tissue

ABSTRACT In the present supplement to the U24 grant 1U24DC015910 for the NIDCD National Temporal Bone Laboratory at UCLA, we aim to make available human inner ear histopathological images for educational and scientific purposes. The specific aim of this supplement to our U24 is the creation of a high-resolution digital archive of the NIDCD National Temporal Bone specimens. Temporal bone H&E digitized images will be shared to the NIDCD Registry and Database. The NIDCD National Temporal Bone Laboratory at UCLA houses one of the largest collections of archival temporal bones (approximately 1200 pairs) in USA. Under the U24 Human Temporal Bone grant, the Laboratory has actively pursued the preservation and acquisition of temporal bones and has collaborated with many basic scientists and clinician scientists. We have met the specific aims of the U24 parent grant: 1) to improve access for the auditory and vestibular research community to human inner ear tissues 2) Optimization of tissue preparation techniques 3) the development of imaging techniques to visualize human middle and inner ear and 4) the training of residents and scientists in the study of the human temporal bone histopathology. The UCLA archival human temporal bone specimens are unique since many of our specimens were obtained with minimal postmortem time allowing for superb morphological preservation. In order to disseminate the human temporal bone histopathology as an educational tool, and as a means of collaboration with scientists, we submit the present request for supplement to the NIDCD National Temporal Bone Laboratory at UCLA for specialized equipment to allow for the creation of high-resolution digital library. The use of celloidin-embedded human temporal bones has been instrumental in driving basic animal inner ear research into the understanding of human ear pathology and has a high potential for the development of effective drug therapies for restoring auditory and vestibular function. The materials generated in this proposal aids research scientists who are conducting animal studies in auditory and vestibular research by providing validation of their findings in the human. The imaging system requested in the supplement will allow to create a high-resolution digital image of hematoxylin and eosin sections of all the temporal bones available in our laboratory. These digital images will be uploaded to the National Temporal Bone registry and database.

Public health relevance
NARRATIVE To preserved and to continue to advance the temporal bone sciences we will create a digital archive of the human ear slides stained with hematoxylin and eosin from available human temporal bones archived at UCLA. The digital images from each temporal bone section will be uploaded to the National Temporal Bone Registry and Database. The digital ear collection will be useful for basic and clinical ear research as well as for histopathological training of otolaryngology specialist.